Ca2+ and secretory dynamics in salivary acinar cells

Abstract.
Secretion of saliva, a watery fluid containing ions and a host of protein constituents, is the primary function of the major
salivary glands. The importance of salivary fluid secretion is most palpable when it is reduced. Commonly, this occurs in
the autoimmune disease, Sjogren’s syndrome (SS). Notably in SS, a decrease in fluid flow occurs prior to any deleterious
morphological changes in the gland that occurs because of immune cell infiltration. Importantly, this indicates that early
in disease, defects in the stimulus-secretion coupling machinery occur prior to any gland destruction. A fundamental
understanding of the earliest alterations in signaling in SS are however lacking. To model early events in SS, we have used
a mouse model where the Stimulator of Interferon Genes (STING) pathway is activated. This ubiquitous pathway, known
to be activated in SS, is initiated by sensing cytoplasmic cyclic dinucleotides derived from DNA arising from virus,
mitochondria and dying cells to result in a type -1 interferon response and thus mirrors key features of SS disease.
Following parasympathetic nervous input, the appropriate stimulation of fluid secretion is absolutely dependent on the
proper localization and activation of the elements of the stimulus-secretion coupling machinery to distinct domains of the
polarized acinar cell. Our preliminary data show that fluid secretion is reduced ~50% following STING activation, but
paradoxically the peak acinar cell Ca2+ signal measured in vivo in an animal expressing a genetically encoded Ca2+ indicator
in acinar cells is markedly augmented. In addition, while stimulated Ca2+ signals are apically confined in physiological
situations, the spatial characteristics of the Ca2+ signal are disrupted in the model. We posit that disruption of the Ca2+
signal contributes to both the initial hypofunction and ultimately the progression of disease. The proposed studies will
investigate the mechanisms occurring at the onset of SS which result in hypofunction together with the pathways
associated with progression of disease. We will use complimentary, but independent approaches to address these goals.
In Specific aim 1, single cell RNA sequencing will be used to identify genes and target pathways in salivary gland cell
populations involved in the disruption of fluid flow and progression of disease and will inform all subsequent studies. We
will validate findings at the protein level and by functional assays. In tandem, we will explore promising candidates
involved in fluid secretion suggested by our preliminary functional data whose abundance, localization or activity is
disrupted in the SS disease models. Where possible targets and pathways will be validated in human tissues provided by
our collaborators at NIDCR. In specific aim 2, we will use in vivo imaging to define mechanisms which are involved in the
disruption of the Ca2+ signal in the disease models. We hypothesize that changes in Ca2+ sequestration together with Ca2+
release/influx mechanisms will be revealed. We hypothesize that the altered Ca2+ signals are a compensatory mechanism
in response to reduced secretion that are ultimately detrimental. Consistent with this idea, mitochondrial morphology is
severely disrupted in the disease model. In Specific aim 3, we will investigate how mitochondrial Ca2+ handling,
bioenergetics and reactive oxygen species production are altered in disease. In total our studies are designed to provide
insight in events occurring at the onset of SS which ultimately should provide targets for novel therapeutic intervention.

Public health relevance
Project Narrative. The secretion of saliva is vital for health and this is most commonly appreciated in disorders such as Sjogren's syndrome where salivary flow is markedly decreased. Following nerve stimulation, the secretion of saliva occurs through the finely tuned choreography of changes in intracellular Ca2+ and activation of ion channels and transporters in specific subcellular domains in salivary gland cells. We postulate these processes are disrupted early in disease and using mouse models of Sjogren’s syndrome, coupled with pathway analysis and functional assays, we will define the events which result in a decrease in secretion and the progression of disease, with an ultimate goal of identifying novel molecular pathways targetable for therapeutic intervention.